Redox Regulation of Sarcoidosis Granulomas and Fibrosis

PROJECT SUMMARY
Sarcoidosis is a pulmonary and systemic granulomatous disease of unknown cause. To better understand
disease mechanisms, we have recently established a novel ex vivo human granuloma model that shares many
structural and molecular features of the disease in human tissues, yielding novel insights into mechanisms
regulating early granuloma formation. In keeping with prior investigations and clinical experience linking
sarcoidosis to elevated levels of angiotensin converting enzyme (ACE) in sarcoidosis tissues, molecular
characterization of the sarcoidosis granuloma model indicates that macrophages participating in sarcoidosis
granuloma formation are regulated by the renin-angiotensin-aldosterone system (RAAS). Our strong
preliminary data shows that sarcoidosis macrophages produce aldosterone, a hormone that promotes
inflammation through the activation of mineralocorticoid receptors (MRs); and we further show that inhibition of
MRs attenuates granuloma formation. We hypothesize that RAAS promotes pathological granuloma formation
and fibrosis in patients with sarcoidosis through activation of MRs and related production of reactive oxidant
species (ROS). In the spirit of the R21 funding mechanisms, this project is highly innovative and has important
beneficial implications for advancing our understanding of sarcoidosis disease mechanisms and for providing
novel therapeutic targets and disease biomarkers. Aim 1 will determine if RAAS/MR activation promotes
sarcoidosis granuloma formation through redox signaling to promote NRF2/heme oxygenase-1 (HO-1)
pathway activation. We posit that MR activation promotes mitochondrial ROS production to trigger
NRF2/HO-1 signaling resulting in alternative macrophage (M2) polarization favoring granuloma formation. Aim
2 will determine if RAAS/MR activation promotes collagen and pro-fibrotic molecule formation by
sarcoidosis granulomas through induction of TGFβ and inflammasome signaling. These studies will
determine if sustained MR activation (by RAAS) promotes pro-fibrotic induction through pathways independent
from NRF2/HO-1; dependent on direct ROS-dependent activation of TGFβ and induction of inflammasome
mediated IL-33 release. The short-term goals of this project are to advance basic understanding of sarcoidosis
disease mechanisms regulating distinct disease manifestations of (1) granuloma formation induced by MR
induced ROS production and downstream pathways regulating granuloma formation (NRF2/HO-1) and (2)
tissue fibrosis relating to TGFβ and inflammasome/IL-33 regulated pro-fibrotic responses. Long-term
aspirations of this project are to address current deficiencies in the field of sarcoidosis as relates to
identifying novel disease-specific therapies targeting granuloma formation and tissue fibrosis, including
repurposing of safe, widely available RAAS modulating drugs (e.g., ACE and MR inhibitors) or antioxidants,
and emerging therapies targeting NRF2, HO-1 and IL-33.

Public health relevance
Project Narrative The proposed project is relevant to the public because sarcoidosis is a common interstitial lung disease of unknown cause that often causes chronic disability and, in some cases, premature death, and for which effective and affordable treatments are not currently available. The successful completion of this project will provide novel insights into the pathogenesis of sarcoidosis to inform the development of more effective treatments, including repurposing existing therapeutic agents. Thus, the proposed research and future scientific and clinical implications are relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge that will reduce the burdens of illness and disability, and is responsive to the NHLBI strategic vision as relates to understanding human biology, reducing human disease, and advancing translational research.